How spatial cues support communication: Interactions between auditory spatial features and task demands across cortical networks

PROJECT ABSTRACT
Improving speech understanding in the presence of background noise by individuals fitted with cochlear implants
is an enormous challenge. Although audibility can sometimes be a limiting factor for benefit, more frequently it is
because the cues that are often responsible for sound source segregation by individuals with normal hearing, are
limited or unavailable. This proposal will alter binaural cues, in the form of magnified ILDs, and use behavioral and
neuroimaging techniques to establish both the extent and the mechanisms of benefit.

Public health relevance
PROJECT NARRATIVE This project will explore the mechanism of modified binaural cues to help cochlear implant users better understand speech in a cocktail-party like environment.